Research Supplement to Promote Diversity: Carlos Torres (R03EB031495 Parent Award)

PROJECT SUMMARY/ABSTRACT
Every year an estimated 19.4 million children do not receive the set of vaccines recommended by the World
Health Organization, leading to 1.5 million vaccine-preventable deaths.1,2 A majority of undervaccinated children
live in low- and middle-income countries and often have limited access to healthcare.2,3 Nearly 6 million of these
children receive at least one vaccine dose, but remain at risk because they have not completed the full dosing
regimen.4,5 A vaccination method that delivers all doses of a vaccine, or multiple vaccines, in a single injection
would enable children with even one-time access to healthcare to be fully protected from the corresponding
infectious disease. Unfortunately, most controlled-release drug delivery systems exhibit continuous release
kinetics, which is vastly different from traditional soluble vaccines administered in multiple discrete doses over a
course of months. One recent study has described the development of biodegradable microparticle platform with
a polymer shell encapsulating a vaccine-loaded core that exhibits delayed, pulsatile release after a period
determined by the polymer degradation rate.6 By injecting patients with a mixed population of particles with
different degradation rates, vaccine can be released as discrete pulses, thereby mimicking traditional vaccination
schedules known to be safe and effective. Unfortunately, the original microparticle production method negatively
affects antigen stability, requires the use of large-gauge needles, and is low-throughput. This project seeks to
overcome these challenges by preparing microparticles using coaxial electrospraying, a single-step fabrication
process that can produce a single aqueous, vaccine-loaded core surrounded by a shell of polymer. The parent
proposal first aims to create small core-shell microparticles with dense polymeric shells that demonstrate the
delayed, pulsatile release of macromolecules in vitro and in vivo using fluorescently-labeled model molecules
and reporter proteins to assess protein stability within the microparticles. This diversity supplement will expand
the scope of work previously proposed to support the work of Carlos Torres, a Hispanic male undergraduate
student at Houston Community College, including the investigation of coaxial electrospraying parameters
between pieces of electrospraying equipment. The goal of Carlos’s work is to identify the key features that affect
core-shell microparticle morphology and release kinetics and develop solutions that allows electrospraying
conditions to be readily transferred between different pieces of equipment. If successful, Carlos’s work will
enhance the reproducibility of science and allow different research groups to work in unison to improve
electrosprayed particle formulations for single-injection vaccination as well as other drug delivery applications.
Ultimately, these particles could serve as a key tool in the fight against infectious disease both in the developing
world where resources are limited and in the developed world, where uninsured children and rural communities
show consistently lower vaccination coverage.7

Public health relevance
PROJECT NARRATIVE Motivated by the 1.5 million vaccine-preventable deaths that occur each year, which are largely due to accessibility challenges in low-resource settings, the parent grant for this proposal seeks to develop a single- injection vaccination platform based on biodegradable microparticles that mimics the antigen exposure profile of current multi-injection vaccination regimens. To do this, we are using coaxial electrospinning to produce microparticles with a core-shell structure, which results in the pulsatile release of antigen after a material- dependent delay. This diversity supplement will support an undergraduate student enrolled at Houston Community College, Carlos Torres, a Hispanic male, as he investigates the effect of electrospraying processing parameters on microparticle morphology and release kinetics with the goal of facilitating the transfer of techniques between equipment and research groups.